Acquisition of an 800 MHz NMR

Acquisition of a state-of-the-art solution phase 4-channel (1H, 19F, 13C, 15N) 800 MHz NMR
spectrometer equipped with a triple resonance cryoprobe and a high throughput sample
changer, enabling essential fragment-based drug screening capabilities, is proposed. This will
enable us to extend essential NMR capabilities at Vanderbilt University, which support a large
NIH-funded research portfolio, both in basic biomedical science and translational biomedical
research. The major user group consists of six NIH-funded faculty, Profs. Walter Chazin, Doug
Kojetin, Jens Meiler, Stephen Fesik, Charles Sanders, and Michael Stone. Many additional NIH-
funded minor users also have need for 800 MHz NMR. This instrumentation will satisfy a
growing demand for fragment-based drug screening applications, as well as increasing
emphasis upon understanding structural aspects of complex binding interactions between
biological macromolecules, especially those which rely on the TROSY effect to enhance
sensitivity and resolution. It will provide essential 19F capabilities, not presently available. It will
provide access to state-of-the-art training in NMR-based structural biology methods for many
NIH pre-doctoral and post-doctoral trainees at Vanderbilt University, including trainees from
primarily undergraduate institutions serving historically under-represented populations in the
STEM and biomedical sciences. Extensive site preparation or renovation will not be necessary
because the proposed 800 MHz NMR will be placed in existing space within the Vanderbilt
University Biomolecular NMR Facility (VUBNMR), operated by the Vanderbilt Center in
Structural Biology (CSB). The VUBNMR Facility is dedicated to studies of biological
macromolecules, fragment-based drug discovery, and complex biomolecular binding
interactions. It is housed in a dedicated building in the Stevenson Science Center, centrally
located on the Vanderbilt campus. It is directed by Prof. Markus Voehler, who has many years
of expertise, both in the operation and laboratory support of high field NMR instrumentation. The
facility houses a helium liquefier serving NMR cryomagnets. The proposed 800 MHz NMR is
anticipated to be used heavily, ~95% of AUT, calculated on a 365 d/yr and 24 h/d basis.
Administrative and financial plans for operating and maintaining the 800 MHz NMR and
managing laboratory operations are in place.

Public health relevance
Acquisition of a modern 800 MHz NMR spectrometer will provide essential new capabilities in high throughput fragment-based drug discovery, 19F NMR, and NMR-based structural biology to six major users and many minor users at Vanderbilt University, supported by NIH funding. It will extend essential capabilities in basic and translational biomedical research and training. It will be used for probing biomolecular binding interactions, and structural and dynamics studies of complex biological macromolecules.